HIV Center for Clinical and Behavioral Studies

Promising new tools for HIV prevention and treatment have stimulated global initiatives to “End the HIV
Epidemic” and reach the “End of AIDS;” however, significant challenges to ending the global HIV epidemic
remain. Biomedical advances for prevention and treatment will not reach their full potential without rigorous
behavioral and social science research to optimize uptake, adherence, and equitable and effective
implementation and scale-up. Thus, we propose a renewed HIV Center for Clinical and Behavioral Studies
that expands on our history of conducting interdisciplinary HIV research and leverages new partnerships to
maximize the potential of biomedical advances, addressing their availability and acceptability to the most
vulnerable populations. The HIV Center is unique among NIMH AIDS Research Centers (ARCs) in being
based in New York City (NYC), a continuing US AIDS epicenter in a state that has the greatest number of
people living with HIV (PLWH) in the US, including ethnic/racial minority populations coping with extreme
economic, health, and social disparities. In 2014, HIV Center investigators and other academicians, providers,
advocates, and policy-makers joined the Office of the Governor of New York State (NYS) to develop a NYS
Blueprint for Ending the Epidemic (EtE). The Blueprint provides the HIV Center with the unique opportunity to
use our home city and state as a “laboratory” to study implementation of EtE initiatives and apply lessons
learned to US and global epidemics. Thus, in the next five years, the HIV Center will be guided by the theme,
The Science of Ending the HIV/AIDS Epidemic (EtE): Efficacy to Effectiveness at Scale, and its emphasis
on implementation research and research at the intersection of behavioral, social, and biomedical sciences.
The HIV Center brings together a cadre of investigators at the forefront of multiple disciplines to address
three Specific Aims: (1) to catalyze intervention and implementation science research necessary to achieve
EtE goals; (2) to translate research into culturally and structurally competent practice and policy for maximum
public health impact; and (3) to increase the capacity of current and future generations of scientists, service
providers, and community and policy leaders to create and implement biomedical, behavioral, social, and
structural HIV prevention and treatment interventions to meet EtE goals. Our Cores ensure methodological
and theoretical rigor, identify and rapidly respond to new trends in the epidemic, support critical research-
practice partnerships, and train new scientists. We complement the Administrative and Development Cores
with three Research Cores: (1) Statistics, Assessment, and Data Management (StAD) Core, focused on
innovative analytic, assessment, and data management strategies; (2) Bio-Behavioral Core, focused on
research at the interface of the biomedical and the behavioral and social sciences; and (3) Implementation
Science and Health Outcomes (ISHO) Core focused on effective, sustained, and equitable achievement of HIV
prevention and care outcomes at scale.

Public health relevance
The HIV Center will continue as a global leader in HIV prevention and the fight to improve health outcomes and reduce HIV-related health and social disparities that disproportionately burden the most vulnerable – women, youth, racial/ethnic and sexual minority populations, and other disenfranchised groups. We will work to meet “Ending the HIV Epidemic” goals by synergizing institutional and intellectual resources; invigorating our multidisciplinary community of scientists, clinicians, and policy-makers; rigorously training a new generation of scientists; supporting research partnerships with public health policy and practice sectors; and translating transformative NIH-supported HIV/AIDS research into real-world practice and policy. We will apply the lessons learned from our research to improve the health and well being of all affected by the HIV epidemic, regardless of where they reside.